Determining the information processing changes that underlie the phenotype of an ASD risk gene in rats

PROJECT SUMMARY/ABSTRACT
Although there has been tremendous progress in identifying high-risk, large effect, genes for psychiatric disease,
we continue to have a very limited ability in understanding how single genes cause the complex symptoms
associate with the disorder. To bridge that gap, genetically modified animals are invaluable, but to take
advantage of such animal models, it is critical to have clear and interpretable behavioral readouts of the effect
of the genetic manipulation. I have recently identified a phenotype consistent with restrictive and repetitive
behavior in a rat haploinsufficiency for a high-risk ASD gene. Restrictive and repetitive behaviors are one of the
core diagnostic features of ASD. Furthermore, I have shown this phenotype to be consistent with improper
functioning of the hippocampus in these animals. The scientific objective of this project is to determine the
changes to the hippocampus and its communication with other brains regions in the context of this high-risk
gene.
The specific aims employ automated measurement of rat behavior, large scale neural recordings during
behavior, genetically modified rats, and functional ultrasound imaging during behavior. The preliminary data
provides a clear phenotype and a strong hypothesis to motivate the physiological studies. The use of these
methods will enable the connection between the phenotype and the underlying neural activity. This will provide
an invaluable framework for future studies into the changes to neural computations in the context of psychiatric
disease processes.
In addition to the proposed studies, this proposal develops a plan to train Dr. Kastner for an independent research
career as a neuroscientist and psychiatrist. This plan is mentored by Dr. Michael Brainard, an expert in the study
of the neurophysiology underlying complex behavior, with the co-mentorship of Dr. Emma Wood Dayan, an
expert in hippocampal physiology and how that changes in the context of high-risk disease genes, and Dr.
Tommaso Di Ianni, an expert in functional ultrasound imaging.

Public health relevance
PROJECT NARRATIVE We continue to have a very limited understanding of the neural computational and information processing changes that underlie the symptoms associated with psychiatric disease. The goal of this project is to leverage behavioral studies to identify the changes to the brain that lead to a clear behavioral phenotype. This work will develop a framework to rigorously connect changes to neural activity and functional connectivity to changes in behavior, laying the foundation to understand more broadly the neurophysiological changes that underlie psychiatric disease.